SCH: Overcoming the Intraoperative Data Desert: Biophotonics, Advanced Sensing, and Control for Automated Surgery

3URJUDP 'LUHFWRU 3ULQFLSDO ,QYHVWLJDWRU /DVW )LUVW 0LGGOH Codd, Patrick J. 352-(&7 6800$5< 6HH LQVWUXFWLRQV See Attached PDF 5(/(9$1&( 6HH LQVWUXFWLRQV See Attached PDF 352-(&7 3(5)250$1&( 6,7( 6 LI DGGLWLRQDO VSDFH LV QHHGHG XVH 3URMHFW 3HUIRUPDQFH 6LWH )RUPDW 3DJH

Public health relevance
This research aims to improve detection of and automated removal of sarcoma tumors in mural models. By combining optical coherence tomography, fluorescent imaging, and computer-guided laser photoablation the intraoperative precision and extent of resection can be maximized over standard practice. Extent of resection studies with the experimental system will be demonstrated and characterized on phantom tissue models and in vivo mural sarcoma models.